Embedded Mental Health Services Postdoctoral Research Training in Health Systems

PROJECT SUMMARY
This application establishes a new T32 training program in embedded mental health services research in
health systems leveraging the resources of the NIMH-funded Mental Health Research Network (MHRN).
MHRN is a consortium of 21 health systems across 16 US states serving more than 30 million patients per
year. Established in 2010, the network provides unique data infrastructure via a common data model,
including all electronic health records, insurance claims and administrative records organized using the same
variables and data definitions across sites enhancing efficient mental health services research. Importantly,
each of the MHRN health systems includes embedded research centers with experienced mental health
services researchers with long histories of NIMH funding. MHRN is a practice-based research network
leveraging close relationships between these embedded scientists and health system leaders, clinicians, and
patients to facilitate an iterative research-practice-policy ecosystem focused on studying key mental health
clinical and research questions. This strong relationship drives mental health care transformation. The
proposed program will include 2 MHRN health systems serving as postdoctoral training host sites, Henry Ford
Health System (Michigan) and Kaiser Permanente Northern California, and provide access, data, and
resources across all MHRN sites. This T32 will support 10 total postdoctoral fellows for 2-year training
programs during the 5-year award period. The program will use a novel training approach with virtual and in-
person training and mentorship embedded within the established infrastructure across the entire MHRN. The
program will integrate an external University-based faculty advisory committee and additional external senior
scholars. The program is interdisciplinary and expects to recruit doctoral-level trainees from many disciplines.
The core training and mentorship model will include the following aims for all postdoctoral trainees: 1) Didactic
training in health services research methods and mental health disorders etiology, prevention, and treatment
tailored for embedded health system research settings, 2) Individualized training and mentorship in grant
writing, dissemination, project management and leadership, professional development, and multi-site study
collaboration and coordination, and 3) Participation in all applicable MHRN health system activities. Our long-
term goal is producing independent scientists, who can engage in practice-based research through the pursuit
of early career funding opportunities for mental health services research.

Public health relevance
PROJECT NARRATIVE The goal of this new T32 program is to provide postdoctoral training in embedded mental health services research leveraging the established infrastructure across the Mental Health Research Network (MHRN), a practice-based research network. The proposed program will offer postdoctoral fellows training and mentorship led by scientists embedded within MHRN health systems in close collaboration with stakeholders. During the 5- year award period, a total of 10 postdoctoral fellows will complete 2-year training programs, including didactics in health services research and mental health disorders, tailored mentorship in grant writing, professional development, project leadership, and multi-site research collaboration, and opportunities to conduct research and participate in ongoing activities across MHRN, in preparation for independent careers with the necessary training to conduct NIH-supported embedded mental health services research.